Illuminating the Druggable GPCR-ome

Abstract
PROJECT SUMMARY
G protein coupled receptors (GPCRs) represent essential molecular targets for a large number of approved as well as investigational medications. Of the 380 or so non-olfactory GPCRs in the human genome around 100 are understudied and/or orphan receptors (oGPCRs). The oGPCRs represent potential therapeutic targets although discovering drugs that modulate them is challenging.
Here we will solve the structures of 15-20 oGPCRs using cryogenic electron microscopy (cryo-EM). The solved structures then will serve as templates for structure-guided drug discovery targeting these oGPCRs.

Public health relevance
Public Health Relevance G-protein coupled receptors respond to signals from light to adrenaline, lipids to chemokine proteins; GPCRs control physiology ranging from vision to respiration, heart rate to learning and memory and are the family of proteins most targeted by therapeutic drugs. Astonishingly, 1/3rd of the pharmacologically relevant GPCRs remain orphans, without specific reagents to control their activity. The advent of new technologies enables the development of chemical probes, genetic reporters and perturbants for the oGPCRs. This project will create novel tools suitable for illuminating the functions and ultimately public health relevance of oGPCRs that will enable new therapeutics for a wide variety of human diseases.